VINE Catheter: Soft, Tip-extending, Robotic Catheters with Shape Control for Endovascular Surgery

PROJECT SUMMARY
Endovascular surgeries (ES) increasingly augment or replace traditional open surgical treatment of brain, liver,
heart, and vascular diseases due to their improved clinical outcomes, faster recovery times, and improved mor-
tality rates. These surgeries are commonly performed by inserting endovascular equipment into the groin or arm
and navigating to distal arteries through a combination of axial loading and rotation of the base of the tools,
utilizing the curved tips to deﬂect into intended locations and vessels. Despite the many beneﬁts of endovascular
surgeries, vascular anatomy, particularly for elderly patients who represent a large portion of those undergoing
such procedures, can demonstrate excessive tortuosity and severe angulation, leading to high-risk , time-intensive
procedures that can only be performed by a select number of expertly trained specialists. The small number
of specialists results in limited access to necessary treatment, and patients are forced to either wait and travel
for treatment or to not receive treatment at all. There is therefore a critical need for new endovascular robotic
surgical tools that are safe, e↵ective, and that enable more surgeons to successfully navigate challenging anatomies.
To address this need, a new soft-robotic approach called VINE – Vascular Internal Navigation by
Extension – will be used. When pressurized with ﬂuid, these VINEs navigate via extension at their tip in a man-
ner analogous to how plants grow, creating shapes with complex curvatures. These VINEs are inherently safer
due to their soft structure and represent a fundamentally di↵erent method of movement. The overall objective of
this work is to characterize the behavior and reﬁne the design of the VINE for ES, including the shape control
methods, and to validate its e"cacy and safety. The central hypothesis is that this new method of shape control
and navigation via tip-extension enables VINEs to safely and e↵ectively traverse the vasculature. The central
hypothesis will be tested by pursuing three speciﬁc aims: (1) characterize and reﬁne small-scale, pre-shaped and
steerable VINE designs for ES, (2) evaluate VINE e"cacy in bench-top models, and (3) validate the safety of the
entire VINE system in an in vivo pig study. This work will serve as a ﬁrst step towards achieving the long-term
goal of creating a soft robotic catheterization system, operable by a large number of surgeons, to increase access
to high-quality surgical treatment.
This work is innovative in that the proposed VINE is the ﬁrst everting, robotic catheter with shape control and
represents a substantive departure from the status quo, which currently relies on pushing semi-rigid instruments
from their proximal end. The expected contribution of this work is a preliminary soft, tip-extending robotic system
capable of safely and e↵ectively navigating around acute turns and through winding paths of the vasculature, which
is signiﬁcant since it will ultimately lead to increased access to high-quality minimally invasive procedures.

Public health relevance
PROJECT NARRATIVE We propose to develop new soft, tip-extending robotic catheters with shape control that have the potential to increase access to endovascular procedures by enabling navigation of vessels that can currently only be performed by a small number of specialists. Our approach represents a fundamentally di↵erent method of movement through the vasculature compared to typical manual and robotic methods that rely on axial loading of semi-rigid catheters, and our approach has the potential to improve safety and e↵ectiveness of endovascular surgical procedures. The proposed research is relevant to public health because it seeks to improve outcomes and ultimately increase access to high-quality minimally invasive surgical procedures.